Rapid culture-free analysis of bloodstream pathogens for transforming sepsis care

PROJECT SUMMARY
Sepsis is a life-threatening organ dysfunction caused by a dysregulated host response to an infection. Majority
of sepsis is bacterial, and is typically accompanied by bacteremia, i.e., the presence of bacteria in blood at 1-104
CFU/mL. Each year, sepsis kills over 10 million people globally, and is the most expensive condition treated in
US hospitals costing over $60 billion annually. It is a medical emergency requiring early recognition and
immediate treatment, but the lack of rapid and actionable tests leads to delays in recognition and treatment of
sepsis, non-optimal treatment, and overuse of broad-spectrum antibiotics resulting in emergence of drug-
resistant pathogens. We propose an integrated “DIMS-Raman” platform to rapidly isolate and analyze bacterial
cells from blood samples by machine learning-enabled Raman spectroscopy within approximately 1-2 h to
provide actionable information to guide treatment in a timely manner. The proposed system combines a novel
yet simple fluidic platform called Density-shift Immunocapture Separation (DIMS) that enables direct separation
of microbial cells from whole blood, with Raman spectroscopy – an analytical technique that generates molecular
fingerprints of targets from the inelastic scattering of light in a sample – combined with machine learning-based
spectral analysis and classification. We envision that target cells isolated by DIMS are concentrated into
micro/nanoliter volumes for direct microscopic observation and Raman spectroscopy at the single cell level,
enabling culture-free enumeration, and machine learning-enabled identification of bacterial strains and
assessment of antibiotic resistance. Our preliminary study using DIMS was able to isolate, concentrate by
10,000x, and image salmonella (~30 CFU/mL) at the single cell level from blood within 3 h. Bacterial cells have
unique Raman signatures, which, using machine learning based spectral analysis have enabled differentiation
of the 30 most common sepsis related pathogens (including methicillin resistant and susceptible S. aureus) with
a 99% classification accuracy using just 10 cells. Moreover, our work demonstrated applications in
heterogeneous mixtures of bacteria species and blood cells in liquid droplets with 92% accuracy. In addition, we
further demonstrated antibiotic co-incubation free susceptibility testing across the four major anti-tuberculosis
drugs with 98% accuracy. The proposed work aims to develop an integrated DIMS-Raman platform for sepsis
by demonstrating integrated isolation, concentration, detection, and Raman analysis at the single cell level of
the most common sepsis-causing bacteria with a sensitivity of 1 CFU/mL from whole blood within 1-2 h. If
successful, the proposed work could eventually lead to a platform capable of returning pathogen type,
concentration, and antibiotic susceptibility of clinically-relevant pathogens from blood without relying on culture,
thus transforming sepsis detection and informing appropriate antibiotic treatment in a timely manner, saving
human lives and reducing the cost of care.

Public health relevance
Project Narrative Sepsis is a medical emergency requiring early recognition and immediate treatment claiming over 10 million lives annually. The lack of rapid and actionable tests leads to delays in appropriate treatment, increased mortality, and overuse of broad-spectrum antibiotics contributing to emergence of drug-resistant pathogens. This project aims to develop a new platform to rapidly isolate microbial cells from whole blood and perform machine learning- enabled single-cell Raman spectroscopy to identify bloodstream pathogens and their antimicrobial susceptibility, which could enable rapid detection and administration of appropriate treatment and save human lives and hospitalization costs.